Building blocks for an HIV-NCD integration Community-Clinical Linkage Model TO enhance the MAP-IT Study: Link2MAP-IT

ABSTRACT
The “Managing Hypertension among People Living with HIV: An Integrated Model” (MAP-IT) parent study is an
ongoing NIH-funded cluster randomized controlled trial of 30 primary healthcare facilities in Akwa-Ibom, Nigeria
(UH3HL154498). MAP-IT aims to compare the effect of practice facilitation (i.e. quality improvement support for
primary care practices) with usual care (i.e. treatment provided by community nurses) on the rate of adoption of
a task-strengthening strategy for hypertension control and change in systolic blood pressure for people living
with HIV (PLWH). In response to PA-20-272, we propose this administrative supplement, “Building blocks for an
HIV-NCD integration Community-Clinic Linkage Model TO enhance the MAP-IT Study” (Link2MAP-IT), which
initiates the building blocks in developing a community-clinical linkage (CCL) model to enhance and integrate
non-communicable disease care for PLWH in Akwa-Ibom State.
Link2MAP-IT will conducts a community asset
mapping (CAM) of the resources and capacities of the estimated 53 community-based organizations (CBOs) in
Akwa-Ibom servicing PLWH to establish an HIV-NCD CCL network. Additionally,
Link2MAP-IT will use a human-
centered design approach to work with MAP-IT local advisory committee to identify the barriers and facilitators of
creating a CCL model for PLWH with uncontrolled hypertension who engage with CBOs in Akwa-Ibom. This
research will advance the potential impact of the MAP-IT study by establishing a more focused pathway for CBO
engagement. It will also contribute to enhancing the reach for hypertension treatment for the MAP-IT study and
will be a critical first step for developing a CCL model to improve hypertension care for PWLH through community
partnership. A first of its kind in Akwa-Ibom, this study will advance the evidence for CCL models for dual disease
burdens in low resource-high need settings.

Public health relevance
NARRATIVE Addressing the increasing burden of non-communicable diseases (NCD) among people living with HIV (PLWH) requires robust community linkage strategies as PLWHs also receive care through community-based organizations (CBOs). This project, Link2MAP-IT, uses the MAP-IT study to initiate the building blocks in developing a community-clinical linkage (CCL) model that enhances and integrates NCD care for PLWH in Akwa- Ibom State, Nigeria. Link2MAP-IT will establish an HIV-NCD CCL network and will identify the barriers and facilitators of creating a CCL model for PLWH with uncontrolled hypertension who engage with CBOs in Akwa- Ibom. This project will advance the evidence for CCL models for dual disease burdens in low resource-high need settings by not only establishing a more focused pathway for CBO engagement, but also by enhancing the reach for hypertension treatment for PWLH through community partnership.